MR Brain Diffusion Tensor Imaging in Schizophrenia

? DESCRIPTION (provided by applicant): This application is a competitive renewal for 4 years of funding which extends earlier work conducted during the previous grant period. In this application we will enhance our understanding of the neurobiology of white matter changes in schizophrenia by introducing novel tools and methods that are more specific with respect to underlying pathology. This work is highly relevant to the overall VA mission, as patients with schizophrenia utilize 40% of the VA healthcare resources. Historically, the role of white matter in schizophrenia has been largely overlooked, with the majority of biological hypotheses focused on abnormalities in gray matter. This is despite the fact that schizophrenia is now viewed as a dys-connection syndrome, and that it is white matter that provides long-range communication among neurons. Only recently, with the introduction of diffusion MRI (dMRI), has attention slowly shifted to investigating the roe of white matter in schizophrenia. Nonetheless, findings to date have not led to an understanding of the etiology or to new pharmacological treatment(s), primarily because dMRI measures are nonspecific to underlying microstructural pathology. New methods, however, are more specific with respect to pathology, and based on our preliminary data using free-water derived from dMRI, and magnetic resonance spectroscopy (MRS), we hypothesize that white matter in schizophrenia is compromised by at least two distinct pathological processes that occur at different stages of the disease, i.e., neuroinflammation and neurodegeneration. Here we will use novel tools and methods to identify the neurobiological nature, time course, and functional consequences of specific changes in white matter in schizophrenia. Specifically, we will use several recently developed MRI acquisition and analysis methods, and apply them to both early onset schizophrenia and chronic schizophrenia populations, as well as to matched healthy controls. In terms of biological hypotheses, we predict that: A) early onset schizophrenia is likel associated with pathology (neuroinflammation) affecting extracellular volume observed using dMRI and magnetic resonance spectroscopy indicators of neuroinflammation; B) chronic schizophrenia is likely associated with increasing cellular pathology (neurodegeneration), observed using dMRI and MRS measures; and, C) both neuroinflammation and neurodegeneration have an effect on axonal conduction transmission speed, evinced using an interhemispheric transfer task, and localization of these changes will predict clinical profile. Longitudinal changes will also be evaluated one year later in the early psychosis patients in order to determine progressive changes in white matter over this time period. The investigation of dMRI, MRS, and EEG methods in schizophrenia will lead to novel findings of white matter abnormalities in schizophrenia, including new information about the role of neuroinflammation and neurodegenerative processes that occur at different stages of the disorder, which, in turn, will provide a new perspective on possible treatment interventions that will likely involve anti-inflammatory agents early in the course of illness.

Public health relevance
PUBLIC HEALTH RELEVANCE: Schizophrenia is a devastating disorder that affects close to 1% of the general population. At the VA, patients with chronic schizophrenia utilize 40% of the VA healthcare resources, and thus an understanding of this disorder is critical to the VA mission. We will use novel measures of Diffusion Magnetic Resonance Imaging (dMRI), Magnetic Resonance Spectroscopy (MRS), and a measure of interhemispheric transfer speed from EEG to separate neurobiological processes of neuroinflammation and myelin degeneration in both chronic patients and patients early in the course of illness. We will also tract first episode patients over time. We expect to see predominantly neuroinflammatory processes at schizophrenia onset, and more myelin degeneration later in the disease. By combining dMRI, MRS, and EEG measures in the same patients, we hope to understand better the underpinnings of white matter pathology in schizophrenia. This knowledge will, in turn, provide a new perspective for treatment intervention that would involve possible anti-inflammatory medications.